Standardizing and Harmonizing Behavioral and Social Science Research Factors in Alzheimer's Disease through Ontology-Based Approaches

ABSTRACT
Behavioral and social science research (BSSR) is instrumental in comprehending Alzheimer's Disease and
related dementia (ADRD) and its far-reaching implications for individuals, families, and communities. BSSR
investigates how behavioral and social determinants, encompassing factors like physical activity, cognitive
engagement, diet, and social interactions, influence the risk of developing AD. This exploration aims to uncover
non-pharmacological interventions that can manage symptoms and enhance the well-being of individuals with
AD/ADRD, including cognitive stimulation programs, behavioral therapies, social engagement initiatives, and
caregiver training. Moreover, BSSR delves into the social, cultural, and environmental elements contributing to
health disparities, informing tailored interventions and policies for various populations, especially underserved
and minority communities. Collectively, this research enriches our understanding of ADRD and guides the
development of interventions, support systems, and policies to enhance the lives of those affected by the
disease. Yet, there are challenges impeding the integration of ADRD-related BSSR data. A critical issue is the
absence of formal representations for BSSR data and limited tools to link comprehensive BSSR information from
diverse sources. This hampers the holistic consideration of BSSR factors in AD-related research, undermining
evidence-based care and support. In response to PAR-23-182, we propose pioneering ontology-based
approaches to formally represent ADRD-related BSSR factors in a standardized manner. We will develop natural
language processing (NLP) methods to extract and normalize BSSR data from Electronic Health Records
(EHRs) and literature. Our project aims to integrate structured and unstructured data across various research
silos, culminating in a comprehensive and normalized knowledge graph incorporating BSSR factors for ADRD
cohorts. More specifically, in Aim 1, we will develop the Behavioral Social Data and Knowledge Ontology for
ADRD (BSO-AD) to standardize BSSR factors. We will also assess the BSO-AD for correctness and suitability,
refining it based on evaluation scores. Aim 2 employs NLP technologies, including state-of-the-art large language
models, to extract and normalize BSSR-related information from clinical notes and literature. This NLP system
will ensure semantic interoperability and consistency in entity recognition and normalization. In Aim 3, we will
create a knowledge graph (KG) to integrate annotated BSSR factors from structured and unstructured sources,
supporting ADRD-related research and applications. We will evaluate the ontology and KG through
demonstration studies and disseminate these resources to the research community, promoting collaborative
research efforts. In summary, our project aims to bridge the gap in ADRD-related BSSR data integration by
standardizing representation, enabling efficient extraction, and fostering collaboration within the research
community. This endeavor will advance our understanding of ADRD and contribute to evidence-based care and
support for affected individuals and their communities.

Public health relevance
PROJECT NARRATIVE Our proposed strategy utilizes both ontology and NLP methods to streamline ADRD-related BSSR data standardization and integration. By establishing a shared ontological framework and employing NLP for information extraction, we aim to foster interdisciplinary collaboration among researchers from diverse fields, facilitating a more comprehensive understanding of ADRD and its behavioral and social aspects. This integrated approach improves data quality, accessibility, and the ability to uncover insights critical to ADRD research.